Pilot and Feasibility Program

PROJECT SUMMARY - PILOT/FEASIBILITY PROGRAM
The mission of the Center for Gastrointestinal Biology and Disease (CGIBD) is to promote multidisciplinary
research to reduce the burden of digestive and liver diseases. The pilot/feasibility (P/F) program is an
important strategy to achieve that mission. The program is designed to help investigators obtain preliminary
data necessary to successfully compete for external funds. The specific aims are: 1) To assure a large pool of
eligible applicants by actively publicizing the program. 2) To enhance rigor and reduce bias through a thorough
scientific merit review process with initial review by members of the CGIBD Executive Committee and content
experts, and a second review and selection by the CGIBD External Advisory Board and community
representative. 3) To improve the chances for subsequent success among awardees by providing mentorship and
oversight. The program supports investigators in the following categories: 1) new investigators; 2) at risk
investigators who will have no independent R01 or R01- equivalent grant support if they do not secure a
substantial grant award in the near future; and 3). established investigators from other areas of biomedical
research to apply their expertise to an area of need in digestive disease research. We place the highest priority
on funding new investigators. During the past 5 years 92% of awards were given to new investigators. Each
year the CGIBD will fund 3 new proposals with budgets of up to $35,000. The Dean of the School of Medicine
provides funds for an additional award.
The review process is highly structured and rigorous using an online process that mirrors that of the NIH. The
Executive Committee and reviewers with expertise in the topic of the application conduct the first phase of
review. The top 8 applications are reviewed by the External Advisory Board who selects candidates for funding
after brief oral presentations by the applicants. Critiques from both levels of review are rapidly shared with the
applicants and reviewers. Following funding, the awardees meet with the CGIBD biostatistician. Their progress
is carefully monitored with formal written progress reports every 6 months. The awardees present their
research at one of our weekly seminars.
Excluding projects that have not been completed, 40/42 (95%) of awardees in the past 10 years have received
subsequent funding with awards totaling more than $38 million. Among the subsequent awards are 17 R01, 2
K23, 5 K01, 1 P01, 5 R35 and 7 R21.The program is an important incubator for the Center. Of our current
members, 71% have previously been supported by a P/F award including the co-directors, associate directors,
assistant directors, and core directors.